IGF::OT::IGF FHHSN261201400011I Cancer Intervention and Surveillance Modeling Network (CISNET) November 2016 Meeting. POP 10/7/2016-12/2/2016. Labor-$13526.88 ODCs $10293.63 TOTAL $23822.51 Eric Feuer

Cancer Intervention and Surveillance Modeling Network (CISNET) November 2016 Meeting.